Efferent-mediated Enhancement of the Cochlear Amplifier

Project Summary
The mammalian cochlea is endowed with a robust efferent innervation called the olivocochlear system, that
begins in the ventral brainstem as two distinct neuronal clusters containing hundreds of cells. Axons from medial
olivocochlear (MOC) and lateral olivocochlear (LOC) neurons travel out cranial nerve VIII where they profusely
collateralize in the cochlea to end as thousands of synaptic terminals on outer hair cells (OHC) and primary
auditory afferents innervating inner hair cells, respectively. By nature of their connectivity, MOC and LOC
neurons are strategically poised to modulate how the cochlea functions at some of the earliest stages of detecting
and encoding sound. As reflected in a number of audiometric measures, activation of MOC neurons can give
rise to both a suppression and an enhancement of cochlear function by modulating the OHC’s contributions to
sound amplification. The release of acetylcholine (ACh) and the activation of nicotinic ACh receptors on OHCs
accounts for the MOC-mediated suppression in multiple mammalian species, but the synaptic mechanisms
underlying MOC-mediated enhancement have not been identified. This is further complicated by observations
that indicate MOC neurons may express a dozen or more different neurotransmitters beyond ACh. As a result,
there is a clear gap in our knowledge regarding how one critical signaling arm of the MOC system operates. To
facilitate a more complete understanding of MOC function in mammalian auditory physiology, two specific aims
will be pursued in the peripheral auditory system of mice. The first specific aim will isolate the MOC-mediated
enhancement phenomenon after pharmacological blockade and genetic ablation of MOC-mediated suppression.
This will allow for a systematic evaluation of MOC-mediated enhancement over a range of varying auditory and
MOC stimulation conditions. The second specific aim will specify and characterize the MOC transmitter and
postsynaptic mechanisms required for MOC-mediated enhancement. To complete these specific aims, we will
leverage recordings of distortion product otoacoustic emissions (DPOAEs) in the anesthetized mouse before,
during, and after electrical stimulation of MOC neurons in the brainstem. Selective pharmacological agents will
be administered directly to the perilymphatic compartment to isolate MOC-mediated enhancement as well as
identify its underlying signaling components. Immunohistochemical studies will be performed in several strains
of mice to localize receptor proteins, integral to the synaptic mechanisms implicated by our pharmacological
observations. These studies are significant as they will provide much needed insights into the diverse synaptic
mechanisms that the MOC neurons recruit to modulate auditory function in mammals. The data captured by this
proposal is critical for probing the functional roles of the MOC system in auditory physiology as well as identifying
novel synaptic processes that can be targeted pharmacologically for combating hearing dysfunction.

Public health relevance
Project Narrative: The medial olivocochlear system (MOC), when activated, can both suppress and enhance cochlear function by targeting the OHC’s pivotal role in cochlear amplification. This research will elucidate the synaptic mechanisms governing MOC-mediated enhancement, and potentially identify novel pharmacological targets for preventing or ameliorating some forms of hearing loss.